The IGNITE II CC: Engagement, Coordination, Demonstration, and Dissemination

Abstract
Achieving the necessary, robust and continually evolving evidence base for genomic medicine and its
implementation in clinical practice requires overcoming many practical and logistical challenges. The
Implementing GeNomics In pracTicE (IGNITE) Network has been and will continue to be strategic in identifying
and disseminating solutions to these challenges. Specifically, we will continue to address the absence of
supporting information technology infrastructure, lack of data standards and interoperability, and insufficient
decision support. The effectiveness of IGNITE in achieving its objectives requires an experienced, and well-
organized coordination center (CC) with strong existing ties to genomic medicine, that can recruit participants,
create a vast resource of best practices for pragmatic clinical trials (PCTs), develop and deploy common
measures and standards, identify solutions to challenges in implementation, develop a platform for data
management and data analysis, and disseminate knowledge to the greater community. The proposed IGNITE
II CC, a partnership between the Duke University Center for Applied Genomics and Precision Medicine and the
Duke Clinical Research Institute, will provide a central resource for coordination, cost-effective PCT design,
adaptation, oversight, and integration for the network. Importantly, we will leverage our successful
leadership of the IGNITE I Administrative CC and our deep expertise in coordination of PCTs. The
members of the CC have notable experience in each area required by the RFA as: 1) a demonstration project
AND Administrative CC for IGNITE I, 2) CC for large networks and genomic medicine studies, and 3) CC for
PCTs. The IGNITE II CC will provide strategic organizational leadership for the development of a novel,
flexible, and adaptable genomic medicine PCT platform, enables seamless communication, sharing of
information to optimize network productivity. The CC will ensure optimal and adaptable PCT design, participant
recruitment, and data collection, develop a comprehensive analysis framework for evaluating the
implementation and clinical effectiveness of the genomic medicine interventions, and help disseminate of
knowledge beyond the network. In addition, the CC will innovate in 1) the implementation of pragmatic trial
designs, electronic data capture (EDC) systems, and improved recruitment strategies, 2) institution of common
measures across the network, 3) creative management of affiliates as a force amplifier for the network, 4)
developing a Genomic Medicine Knowledge Base for dissemination, 4) creating a durable longitudinal data
source from IGNITE participants and 5) developing a focus on sustainability. Our team's unparalleled track
record of collaborative genomic medicine research and nationally recognized expertise in coordinating IGNITE
I, large networks, and PCTs uniquely positions us to facilitate the completion of high-impact genomic medicine
PCTs and advance the integration of genomic into clinical care.

Public health relevance
Project Narrative The purpose of this project is to provide efficient and effective implementation of the chosen pragmatic clinical trials and coordination of the IGNITE Network and to facilitate dissemination and communication with relevant communities outside the network. The success of this proposal will help facilitate knowledge translation from the genomic demonstration projects into the research and clinical communities thereby accelerating the translation of proven tools into real world settings.